In Vitro Screening Core

The in vitro screening core, overseen by Drs Nancy Connell and Barry Kreiswirth, will provide comprehensive screening services for susceptibility and cytotoxicity determination for candidate compounds provided by the project directors. The standard wild type bacterial strains represent Mycobacterium tuberculosis (both actively growing and non-replicative), other pathogenic mycobacterial species, the ESKAPE pathogens (Enterococcus faecium. Staphylococcus aureus, Klebsiella pneumoniae, Acinetobacter baumannii, Pseudomonas aeruginosa, and Enterobacter species) and bacterial Select Agents (Bacillus anthracis, Francisella tularensis. Yersinia pestis, Burkholderia mallei, Burkholderia pseudomallei, Rickettsia prowazekii, and Coxiella burnetii). In addition, the Public Health Research Institute has extensive collections of bacterial and fungal pathogens in collaboration with private, public and VA hospitals in the New York/New Jersey Metropolitan area, as well as hospitals throughout the world. The bacterial strain collection of drug susceptible and drug resistant organisms is derived largely from bloodstream, soft-tissue, burn, wound, pustules, and respiratory fluids specimens. Finally, the in vitro screening core will provide cytotoxicity screening in mammalian cells (VERO, J774.1, RAW, THP1) and intracellular antibiotic efficacy studies.

Public health relevance
The combined long-term experience ofthe members ofthe In Vitro Screening Core ensures that this important early step in drug discovery is carried out with safety, efficiency and precision.